COBRE: OUHSC: ADMINISTRATION, MENTORING, & RECRUITMENT CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The Administrative, Mentoring, and Recruitment (AMR) Core module is responsible for the fiscal and procedural management of the COBRE program. All reports related to PJI and Core modules will be prepared by the AMR. The Visiting Scholars program will be the responsibility of the AMR Core. The alterations and renovations proposed will be overseen by the AMR Core. Salaries for clerical staff and all mentors will be paid through this module. IAC and EAC meetings will be arranged by the AMR straff, who will also record minutes of each meeting and prepare written reports.